Administrative Core

In response to RFA-RM-18-031, we will establish a “Data Center for Acute to Chronic
Pain Biosignatures” at Johns Hopkins University (JHU). The Center will serve as the
Data Integration and Resource Center (DIRC) for the Common Fund Acute to Chronic
Pain Signatures (A2CPS) Program. The Center will consist of three components and an
Administrative Core (AC). The AC will be led by the Principal Investigators, Martin
Lindquist and Tor Wager, with support from a steering committee consisting of the
leadership of the various components of the Center and external consultants with
significant experience with leading large-scale multisite projects. The AC will oversee
and manage the Center components, including fiscal management; personnel
management; scheduling and organization of meetings; and maintenance of resources.
The AC will also be responsible for facilitating communication and interaction between
the components of the Center, as well as with the Clinical Coordinating Center, Multisite
Clinical Centers, Omics Data Generating Centers, and NIH staff. It will: (1) reduce
administrative barriers across the A2CPS consortium by providing management
resources; (2) facilitate presentation of consortium results to the broader scientific
community; (3) serve as a central hub for organizing recurring A2CPS consortium
meetings, including both face-to-face and virtual meetings; (4) provide regular
quantitative updates on enrollment, patient assessments, data deposition, data quality,
and data usage statistics, both to the NIH and to other members of the A2CPS
consortium; and (5) maintain access to the necessary infrastructure for accomplishing
the specific aims of Center, including research, collaboration, and dissemination.
Overall, the AC will promote a stimulating intellectual environment to knit researchers
involved in A2CPS activities into a strong interdisciplinary community.